Translational Coordination and Dissemination Center for the SCGE Consortium

PROJECT SUMMARY
The goal of the NIH Common Fund’s Somatic Cell Genome Editing (SCGE) program is to take
advances in technologies aimed at genome editing and delivery system approaches to correct
disease-causing mutations developed in Phase I and translate these efforts into the clinic during
Phase II. The SCGE Translational Coordination and Dissemination Center (TCDC) at the
Medical College of Wisconsin (MCW) will continue the efforts of the Phase I SCGE
Dissemination and Coordinating Center acting as the hub to support the three lab and clinical
trials-based initiatives in a coordinated effort to facilitate the dissemination of protocols, best
practices, SCGE results, and develop a network of collaboration. The SCGE TCDC at MCW
brings a team of experienced investigators, platforms for effective communication and tracking
of deliverables and milestones and demonstrated success in strategic collaborations within the
consortium. The overall goal for the SCGE TCDC is to support the SCGE Consortium and work
cooperatively with all initiatives, projects, and members to facilitate the objectives of the entire
SCGE Consortium. To accomplish this, the MCW TCDC will 1) build upon and extend the
current communication platforms to facilitate communication among participants, 2) develop the
infrastructure to collect, digest, annotate, integrate, and distribute data and resources generated
within the SCGE Consortium, and 3) create a robust platform for collaboration within the SCGE
Consortium and with outside partners. The MCW TCDC will create the infrastructure to develop
policies, track progress within the consortium, communicate within and beyond the consortium,
develop outreach and educational activities to support the process of moving pre-clinical studies
through the regulatory process, into clinical trials, and eventually to the patient. To disseminate
data and resources developed within the SCGE Consortium, the SCGE Platform will be
assembled to store, query, visualize, and analyze the outcomes of the SCGE initiatives. The
MCW TCDC team will facilitate the administrative and management activities to support the
overall success of the program.

Public health relevance
PROJECT NARRATIVE The proposed Translational Coordination and Dissemination Center (TCDC) for the Somatic Cell Genome Editing Consortium (SCGE) will support integration of activities across the SCGE Program, using the extensive expertise of the team of investigators and program staff at the Medical College of Wisconsin. The SCGE TCDC will coordinate management and communication, establish platforms for communication and outreach, data and resource dissemination, and support intra-consortium collaborations. The goal of the SCGE TCDC is to facilitate and accelerate translational research projects from the pre-clinical stage through regulatory approval and clinical trials.